Center for Improving Care Delivery for the Aging (CICADA)

REVISED Project Summary – Analysis Core
The Analysis Core of the proposed renewal of Penn’s Center for Improving Care Delivery for the Aging (CICADA) fosters rigorous inquiry in health services research (HSR) and related quantitative and qualitative skill development by developing infrastructure to promote advances that improve the health, wellbeing, function, and independence of older Americans. The renewed Analysis Core will build on its current focus on health economics and quantitative skills by adding new capacity in qualitative, mixed methods, and implementation science approaches. These additions will expand our ability to promote cutting-edge research methods that center the voices of patients and communities, in support of true transformation in health care delivery. It will also equip Scientists with a full suite of HSR skills needed to understand and address complex, multilevel contextual factors contributing to the health and wellbeing of older Americans. The Analysis Core supports new Scientists and CICADA Alumni by leveraging Penn’s unique resources. Providing access to these resources enables RCMAR Scientists to develop into productive, independent investigators focused on aging. With these unparalleled resources, CICADA is able to recruit the most talented potential researchers in the field for training and mentorship to address health services issues confronting aging populations.

The Analysis Core has developed, supported, and maintained a CICADA research infrastructure of data resources, analysis support, and methodological expertise that is easily accessible to RCMAR Scientists and CICADA Alumni. To support this, our four Specific Aims are: (1) To support RCMAR Scientists with resources for quantitative research including datasets for conducting high-quality, high-impact research on health care delivery for aging populations; access to skilled data analysts; and a high- capacity, secure computing environment; (2) To provide RCMAR Scientists with resources for qualitative and mixed methods research including data collection, transcription, analysis, and interpretation; (3) To train RCMAR Scientists in the methodological skills necessary for independent careers in HSR, through individualized mentorship and training in quantitative, qualitative, and mixed methods approaches that are tailored to their research and career goals; (4) To extend Analysis Core consultation services to all CICADA Alumni, to support their ongoing science related to improving health care delivery in aging and strengthen the CICADA network.